Enhancing Human and Animal Food Testing in North Carolina in Support of an Integrated Food Safety System: Chemistry Track 3

Research & Related Other Project Information Project Summary/Abstract Component: Chemistry Track 3 The Food & Drug Protection Division (FDPD) within the North Carolina Department of Agriculture & Consumer Services (NCDA&CS) will support a nationally integrated and prevention-focused food and feed safety system by increasing sample testing activities and making data available to state and federal partners. FDPD Laboratory has partnered with FDPD’s Feed Program, North Carolina’s animal feed regulatory program, to identify commodity-hazard pairs of national and state significance and develop surveillance programs to better characterize the risks these commodity-hazard pairs pose to animal health and consumer confidence. In Year 1, FDPD will collect and analyze 250 pet food samples for aflatoxin. Because the FDPD Feed Program has fully implemented FDA’s Animal Feed Regulatory Program Standards and proposed laboratory analyses are included in FDPD Laboratory’s scope of ISO 17025 accreditation, FDPD is confident that all data submitted to FDA will be accurate, precise, and actionable. Data packages for violative samples will be submitted promptly to FDA, and FDPD will collaborate with FDA to identify and implement appropriate response strategies. Non-violative data will be reported to FDA quarterly to support risk evaluations of each hazard-commodity pair.